Dysregulated NFkB Pathway Signaling In Myeloproliferative Neoplasms

Project Summary/Abstract
Myeloproliferative neoplasms (MPNs) are chronic blood disorders that that can cause severe symptoms and
early death. New treatments have become available that help ameliorate symptoms, but they do not reliably slow
or halt disease progression. We seek to better understand what drives disease development and progression in
MPNs, so that we can develop better therapies for patients with these diseases.
Our preliminary data indicates that the NFkB pathway is abnormally activated in MPNs. We hypothesize that
NFkB pathway signaling contributes to the development of MPNs. Therefore, we have proposed a combination
of mouse and human studies to determine how NFkB contributes to MPN pathogenesis, and to evaluate whether
inhibition of NFkB pathway signaling may have potential therapeutic benefits for MPN patients.

Public health relevance
Project Narrative Myeloproliferative neoplasms (MPNs) are clonal hematologic malignancies that cause significant morbidity and have the propensity to transform to acute leukemia. Current treatment options for MPNs are limited. The studies proposed here will provide deeper insights in the pathogenesis of MPNs, and potentially lead to the development of more effective therapies for patients with MPNs.